Glucocorticosteroid Action In Inflammatory Disease

Abstract 1. Important scientific accomplishments supported by R37HL068546. Since submission of this proposal in the fall of 2008, the Pl and his laboratory have published a total of 51 manuscripts, of which 33 were supported by this proposal. Our productivity has been excellent recently; just in the first four and one half months of 2013, we have published eleven papers, of which seven appeared in the Journal of Allergy and Clinical Immunology, the leading Allergy-Immunology journal (impact factor approximately 11) and 7 were supported by this grant. This report is divided into sections that are oriented toward selected relevant ongoing projects. Many of the in vivo studies described in this report utilized patients with active chronic rhinosinusitis (CRS) and controls having surgery for non-inflammatory conditions. The Northwestern University (NU) group obtains and analyzes tissue samples, lavage and epithelial scrapings from over 250 tertiary care patients per year, enabling the translational work described in this proposal. One of the important studies in the proposal is to perform a clinical trial testing the impact of prednisone treatment on innate immunity, barrier, adaptive immunity and inflammatory responses in CRS. As described in this report, we are near completion of sample collection and we will very soon have a rich collection of important human samples from patients treated with prednisone, or not treated, with which to test some of the hypotheses described in the original proposal.

Public health relevance
RELEVANCE (See instructions): We are trying to understand how anti-inflammatory steroids like cortisone inhibit diseases of the nose and lungs like hay fever, asthma and sinus disease. We use tissue samples from patients with disease vyho are undergoing surgery as a treatment for sinus disease to study the causes of their disease and how steroids improve their condition. This grant has previously supported many important studies on this topic in the past.